MAGIC-PHIV: Microbiome and Gut Inflammation in Cardiometabolic Health in Youth with Perinatally Acquired HIV

Project Summary/Abstract
There are 2.1 million children under 15 years living with HIV worldwide; the vast majority have
perinatally acquired HIV (YPHIV) and reside in Eastern and Southern Africa. YPHIV are now expected to live
through adolescence and well into adulthood, such that adolescents now represent the largest growing
population living with HIV. Several comorbidities, including cardiometabolic, have been associated with
heightened immune activation and inflammation despite viral suppression in adults living with HIV. The
mechanisms causing HIV-associated immune activation, remain incompletely understood, but alteration of the
interplay between gut mucosa and the compositional and functional shifts in microbiota appear to play a central
factor.
Despite significant advances in our understanding of how HIV disrupts intestinal integrity, key
limitations in existing studies include (1) the underlying molecular mechanisms of many microbiome
associations remain unstudied, such as bacterial functional dynamics or immune modulation, (2) the lack of an
appropriate control group to address potential environmental confounders, and (3) the lack of investigations in
YPHIV specifically in sub-Saharan Africa where the vast majority of YPHIV reside.
The overall goal of this project is to obtain new insight into gut dysbiosis in YPHIV and to identify
unique microbiome-related inflammatory signaling cascades related to metabolic disturbances.
We will use a multi-omics approach to identify alterations in the gut microbiome, at a strain and
functional level in YPHIV and identify microbiome and metabolite pathways related to immune
activation and metabolic disturbances. We will address our hypothesis through three aims: 1) we will
characterize and compare the gut microbiome in YPHIV and an uninfected comparison group using
metagenomics and metabolomics; 2) we will correlate our existing data on immune activation and inflammation
to the microbiome data generated; and 3) we will identify unique microbiome-related inflammatory signaling
cascades to metabolic health (insulin resistance, adiposity and dyslipidemia). This study will build on the
existing and well-phenotyped cohort of virally suppressed YPHIV and age-and sex- matched uninfected
comparison group in urban and rural Uganda and utilize repository specimens.
The 2 cohorts in urban and rural settings will allow for data validation and replication, a major criticism of prior
observational omics studies. This will serve as preliminary data for future grant applications focused on the
application of existing and development of novel and precision therapeutics that may have a considerable impact
on both survival and quality of life in this young population by decreasing cardiometabolic complications.

Public health relevance
Project Narrative This proposed study would allow us to further investigate the gut dysbiosis in youth with perinatally acquired HIV or alterations in the gut microbiome and metabolites in a multi-omics manner to provide insight into the mechanisms underlying host-microbiome interactions, immune activation and metabolic health.